The molecular epidemiology of enteropathogenic (EPEC) and enteroaggregative (EAEC) Escherichia coli among adult patients in Seattle

PROJECT SUMMARY/ABSTRACT
Infectious gastroenteritis is a leading cause of morbidity and mortality worldwide.
Diarrheagenic E. coli (DEC), particularly enteropathogenic (EPEC) and enteroaggregative
(EAEC) E. coli, are well established as important causes of gastroenteritis in infants living in low-
and middle-income countries (LMICs). Although some observations suggest that adults in LMICs
may asymptomatically harbor DEC and that DEC may be a frequent but unappreciated cause of
diarrhea in young children in HICs, the contribution of these organisms to gastrointestinal (GI)
illness in adults living in high-income countries (HICs) is poorly understood.
Multiplex PCR panels enabling rapid detection of the common causes of infectious
gastroenteritis, including EPEC/EAEC, were approved by the FDA in 2014, and are increasingly
used by clinical laboratories. Recent studies employing multiplex panels indicate that DEC are
commonly found in adults in HICs. A multicenter study of patients with gastroenteritis in 10
European countries found that EPEC was the most common pathogen detected. However,
EPEC/EAEC were frequently found in samples containing multiple pathogens, raising questions
about their clinical significance. In our laboratories at the University of Washington, EPEC and
EAEC comprise 22.5% and 12.3% of all positive stool panel results, respectively.
In this proposal, I plan to perform both retrospective and prospective studies to better define
the clinical significance of EPEC/EAEC in U.S. adults. The specific aims are to: 1) perform a
retrospective analysis of the clinical features, risk factors, antimicrobial susceptibility, and
outcomes of symptomatic adult patients with stool samples positive for EPEC/EAEC, and 2)
create a repository of EPEC/EAEC strains from symptomatic adult patients using prospectively
collected residual stool samples and perform whole genome sequencing (WGS) to define the
molecular epidemiology of DEC in Seattle adults. These studies will provide new insights into the
clinical importance of DEC in HICs and inform strategies for their management and prevention.
The research will be supplemented by coursework and specialized training activities as part
of a five-year career development plan to allow me to become an independent investigator.
Intensive training in next-generation sequencing technologies and bioinformatics with mentoring
by experts in the fields of infectious diseases and bacterial genomics will allow me to achieve my
long-term objective of becoming a productive independent investigator with a focus on the
molecular epidemiology of bacterial infections.

Public health relevance
PROJECT NARRATIVE Multiplex molecular panels have facilitated the diagnosis of patients presenting with acute diarrhea and enabled the rapid detection of diarrheagenic E. coli which were previously overlooked by conventional clinical laboratory methods. Enteropathogenic (EPEC) and enteroaggregative (EAEC) E. coli are now among the most common pathogens detected by these panels. Yet, although both are established as causes of diarrhea in infants living in developing countries, little is known about their clinical relevance in adult patients living in high-income countries. The proposed research will examine the clinical features, epidemiology, and antimicrobial resistance of EPEC/EAEC infections in U.S. adults to better understand their importance and to inform strategies for their prevention and management.